A novel therapeutic approach to treat life-threatening recurrent urinary tract infections in postmenopausal women

PROJECT SUMMARY
Poor management of recurrent urinary tract infections (rUTIs) in women can lead to severe and potentially
life-threatening complications such as septicemia, septic shock, renal failure, and even mortality. Post-
menopausal women are particularly vulnerable to rUTIs due to decreased estrogen levels, which promotes
changes in vaginal bacterial colonization, facilitating the migration of bacteria up the urethra and into the bladder,
where they cause infections. The primary uropathogenic bacterium responsible for rUTIs is Escherichia coli (E.
coli), accounting for 95% of UTIs, followed by Proteus mirabilis, Enterococcus faecalis, Staphylococcus
saprophyticus, Staphylococcus epidermidis, and Klebsiella pneumoniae. An ideal solution for treating rUTIs in
women would be to target a broad spectrum of uropathogenic bacteria, thereby preventing recurrent infections.
Currently, the most common prophylactic approach for rUTIs involves the daily use of low-dose oral antibiotics,
which have shown success in reducing symptomatic UTI recurrences. However, systemic circulation of these
antibiotics often leads to adverse side effects, resulting in poor patient adherence to prescribed regimens. These
challenges highlight the need for a prophylactic solution that delivers long-term therapy directly to the bladder,
reducing the overall treatment burden on patients.
Watershed Medical, Inc. is pioneering the development of an innovative drug delivery platform designed for
local drug delivery in the bladder. The company has made substantial progress in creating an optimal
prophylactic solution for rUTIs. Amikacin, a well-established antibiotic known for its safety and efficacy against
E. coli, gram-negative bacteria, and Staphylococci species, was selected as the preferred antibiotic. Initial human
studies have demonstrated that Watershed Medical’s product is retained in the bladder through multiple voiding
cycles, remains comfortable, and can provide therapeutic Amikacin concentrations for at least 4 weeks and up
to 3 months, all while not obstructing urine flow or bladder function. In this SBIR Phase I project, Watershed aims
to make the entire drug delivery system capable of self-eliminating after the drug depot is depleted, thereby
avoiding the need for additional procedures to remove the implant. The company plans to optimize the system
for sustained release of Amikacin at therapeutic concentrations within the urinary bladder, with the added benefit
of self-elimination once therapy is complete. This advancement represents a significant stride toward improving
the quality of life for post-menopausal women dealing with rUTIs. The final product will allow for easy intravesical
administration through the urethra into the bladder, extending drug release for up to 3 months to prevent UTIs.
It will then self-eliminate on a similar timescale once the drug reserves are depleted, facilitating the excretion of
all system components through urination without causing urethral obstruction.

Public health relevance
PROJECT NARRATIVE Through this SBIR proposal, Watershed aims to develop an innovative intravesical drug delivery system that directly targets uropathogenic bacteria within the bladder with potent antibacterial therapy over an extended period. This novel approach seeks to break the cycle of recurrent infections, offering a transformative solution for patients who have failed standard medical treatments. By focusing on localized, sustained delivery rather than systemic approaches, Watershed’s solution reduces patient burden and provides a more effective, low- compliance therapy to combat recurring UTIs and improve quality of life.